Johns Hopkins Training Program in Biomedical Informatics and Data Science

 PROJECT SUMMARY
Johns Hopkins University has recently re-established a multi-disciplinary, multi-school education
program in Biomedical Informatics and Data Science (BIDS). The program is centrally coordinated and
managed by the newly established Section of Biomedical Informatics and Data Science (BIDS) in the Division
of General Internal Medicine. Faculty are drawn from the Johns Hopkins School of Medicine, the Bloomberg
School of Public Health, the Whiting School of Engineering, the School of Nursing, and the Krieger School of
Arts and Sciences. The program is structured around four tracks: Translational Bioinformatics, Clinical
Research Informatics, Healthcare/Clinical Informatics, and Public Health Informatics. The program is built on
the decades of informatics training tradition fostered by the Welch Medical Library and the Division of Health
Sciences Informatics, now consolidated in the new BIDS Section. The new organization has established tight
integration with the University and School of Medicine Education leadership, support systems, and
infrastructure. We have revamped and extended our core curriculum to balance traditional informatics topics
with current data science principles and methods. Specialized curricula have been developed in depth for each
academic track of the program. Because of our newly formalized administrative structure, students are now
free to take elective courses anywhere in the University with tuition reciprocity. Students also have access to
the deep bench of research programs across informatics, computer science, biomedical engineering, and data
science throughout the university, anchored by an ever-growing portfolio of BIDS grants and cooperative
agreements in the BIDS Section such as the National COVID Cohort Collaborative (N3C). Thus, BIDS students
have unprecedented opportunities for applied practica at depth to enrich and reinforce their education, provide
a basis for theses, and more importantly achieve experience as collaborators, contributors, and authors. The
University and School of Medicine provide state-of-the-art clinical and basic science data-analytics
environments, including our Secure Analytic Framework Environment (SAFE) virtual machines, the Precision
Medicine Analytics Platform (PMAP), the state HIE population-based EHR analyses platform (on PMAP), and
well-curated clinical data warehouses in OMOP, PCORNet, ACT, and TriNetX formats. Training in biomedical
ethics and the responsible conduct of research is deeply embedded in all practica involving patient data.
Students have opportunity to work with well-established, well-funded research mentors, and to receive
instruction from faculty with a deep commitment to education and training. The strengthening of translational
science, multidisciplinary teams, and enterprise-class infrastructure and computer support across Johns
Hopkins University provides students with opportunities to witness and participate in the new shape of
collaborative science into the future.

Public health relevance
 PROJECT NARRATIVE Johns Hopkins University is committed to leveraging the full spectrum of faculty and data in a multi- disciplinary training program for Biomedical Informatics and Data Science (BIDS). The BIDS program is structured around four tracks: Translational Bioinformatics, Clinical Research Informatics, Healthcare/Clinical Informatics, and Public Health Informatics. Opportunities for learning and application through well-funded research enrich this training experience.